The NICU Antibiotics and Outcomes (NANO) Trial

ABSTRACT
The goal of the NANO (NICU Antibiotics and Outcomes) Trial is to study the longstanding clinical practice of
empirically administering intravenous antibiotics to newborn extremely low birthweight (ELBW) infants. ELBW
infants commonly receive antibiotics immediately after birth and then for 2-3 subsequent days while clinicians
await microbiology culture results. Typically, these culture results are used to guide a decision to continue or
discontinue antibiotics based on the presence or absence of a bloodstream infection. The assumption underlying
this practice is that early antibiotic administration will improve outcomes in infants undergoing evaluation for
early onset sepsis (EOS). However, there are no data to support or refute this assumption, and numerous
studies have shown that >98% of ELBW infants receiving empiric antibiotics (EA) do not have EOS. Recent
microbiome research has demonstrated that broad-spectrum antibiotic exposure is associated with adverse
childhood outcomes, and this may be particularly relevant during a critical window of early bacterial colonization
in newborns. We simply do not know whether early EA for ELBW infants improves health outcomes, worsens
outcomes, or does not affect outcomes. Data from our group and others document the impact of antibiotics on
microbiome development and demonstrate a dose-dependent association between antibiotic days and a
composite outcome of late onset sepsis (LOS), necrotizing enterocolitis (NEC), or death in ELBW infants.
To formally study whether the incidence of adverse outcomes is higher in infants receiving EA in the first week
of life compared to babies receiving placebo, we propose the NANO Trial, an 802-subject placebo-controlled
multicenter randomized clinical trial. We target a population of infants for whom the clinical decision to use or
not use EA is most challenging in 2018. We will enroll clinically stable ELBW infants with gestational age ≤28
weeks, excluding those at high risk for EOS (e.g. suspected exposure to intraamniotic infection) and those at
low risk for EOS (e.g. delivery via uncomplicated caesarean section for maternal indications). The aims of the
study are (1) To test the hypothesis that the composite incidence of LOS, NEC, or death in infants that receive
EA is significantly different than the incidence among infants that receive placebo, (2) To test the hypothesis that
fecal samples in the first month of life from infants receiving EA will contain lower diversity and higher abundance
of pathogens than fecal samples from infants receiving placebo, and (3) To compare somatic growth (weekly
weight and length z-scores) in infants receiving EA and infants receiving placebo (exploratory aim). The results
from this study may validate current clinical practice patterns regarding antibiotic administration, or they may
provide a critical rationale for further reducing antibiotic usage in the NICU. In addition to improving outcomes
for individual babies by reducing antibiotic exposure, such a change could mitigate the growing worldwide burden
of antibiotic resistance and nosocomial infections.

Public health relevance
PROJECT NARRATIVE This award will support a much-needed clinical trial to scrutinize the practice of giving antibiotics to preterm infants immediately at birth. We will focus upon a population of infants for whom there are no widely accepted guidelines on this topic. Results from this trial will aid practitioners who regularly face the challenging decision of whether or not to prescribe antibiotics for newborns. The trial could have an immediate impact on routine hospital care of preterm infants, with the potential to reduce antibiotic usage and resistance while also improving outcomes in this fragile population.